DOWN SYNDROME CONNECT AND PREGSOURCE SUPPORT

The purpose of this contract is to provide support for 1. Maintenance and enhancement of the first national Down syndrome patient registry known as DS Connect. DS connect is to provide direction for the field, necessary research resources. 2. Completion, maintenance, and enhancement of a pregnancy registry known as PregSource. Crowdsourcing to Understand Pregnancy (PregSource) 3. Maintenance of the RDPR 4. Creation of additional designated registries that would reside in this secure web environment. DS connect is to provide direction for the field, necessary research resources.